Neuronal Mechanisms of Obesity and Hypertension: Role of the BBSome

Abstract:
Obesity which has become common in the United States is a major cause of hypertension, a principal
reversible risk factor for cardiovascular disease. However, the mechanisms underlying the relationship
between obesity and hypertension remain largely unknown. The goal of this proposal is to identify the neuronal
and molecular processes that control energy homeostasis and blood pressure and how dysregulation in these
processes contribute to obesity and obesity-associated hypertension. This proposal is based on our recent
work demonstrating the importance of neuronal Bardet Biedl syndrome (BBS) proteins in the regulation of
energy homeostasis and blood pressure. We discovered that the BBSome, a complex of eight BBS proteins, is
required for the trafficking of receptors that underlie neural control of energy homeostasis. We further
hypothesize that defects in the hypothalamic BBSome contribute to common dietary obesity and associated
increase in sympathetic nerve activity and blood pressure. This is supported by our recent intriguing
preliminary data implicating dysfunction of the BBSome in the hypertensive high fat diet-induced obese mice.
To test our hypothesis, we will investigate whether restoring the BBSome in the hypothamus of diet-induced
obese mice alleviate the increased adiposity, energy imbalance, activation of the brain renin-angiotensin
system and the increase in blood pressure and sympathetic nerve activity. We will also determine the cellular
processes underlying the BBSome-mediated trafficking of the receptors regulating energy homeostasis and
use chemogenetics to assess the specificity and extend of the defects caused by disruption of the BBsome in
hypothalamic neurons. These innovative studies which will employ unique and sophisticated genetic strategies,
neuro-techniques and physiologic approaches should unravel novel mechanisms that underlie obesity and
obesity-associated cardiovascular risks, making our work of high clinical relevance. Insights into the cellular
and molecular processes that control energy balance and cardiovascular function may make it possible to
selectively interfere with the damage obesity inflicts on cardiovascular function.

Public health relevance
Project Narrative The prevalence of obesity has reached epidemic proportions due to the unlimited access to food and an increasingly sedentary life style. Obesity is commonly associated with elevated blood pressure which promotes cardiovascular diseases, but the processes involved are not well defined. This project is focused on understanding the biological events that are important for the control of body weight and blood pressure and clarify the processes that underlie the development of obesity and high blood pressure.